Longitudinal MRI imaging of clock gene expression in mice brains

PROJECT SUMMARY/ABSTRACT
The ability to precisely track gene expression is fundamental to unraveling the complexities of brain function,
elucidating the mechanisms underpinning neurological disorders, and devising targeted diagnostic and
therapeutic interventions. While bioluminescent imaging (BLI) has traditionally been the primary method for
monitoring gene expression in living animal models, it has inherent limitations such as limited optical signal
penetration and reliance on external detectors. In contrast, magnetic resonance imaging (MRI) offers exceptional
capabilities for deep tissue imaging and full-brain coverage. However, existing molecular MRI-based methods
have been hampered by low signal-to-noise ratios or potential cell toxicity when sensor overexpressed. In this
proposed project, we introduce an innovative optical MRI (oMRI) technique for the time-resolved visualization of
gene expression patterns within living brains. This novel imaging approach harnesses the strengths of
bioluminescent imaging for molecular specificity and sensitivity, in conjunction with MRI's capacity for 3-
dimensional imaging and high spatiotemporal resolution. We achieve this by directly associating bioluminescent
signals with hemodynamic MRI signals using optogenetic tools, allowing us to map the expression of target
genes across both space and time. In Aim 1, we will implement the oMRI strategy to image rhythmic clock gene
expression in living mouse brains, building on our already validated luciferase-opsin pair design. We expect the
oMRI technique to detect differential Per2 expression levels in mice brains exposed to 12-hour light and dark
cycles. This pioneering imaging strategy will establish a foundation for tracking Per2 and other core clock genes
in the brain and significantly advance Alzheimer's disease research. In Aim 2, we will advance the oMRI toolkit
and develop dual-channel gene expression imaging. This will allow us to study the longitudinal interactions of
multiple molecular events during AD progression, particularly the relationship between clock gene disruptions
and other AD pathological events. We anticipate that this novel MRI technique will revolutionize our
understanding of the circadian system's role in AD development, paving the way for discovering biomarkers for
early AD diagnosis and intervention.

Public health relevance
We propose to develop an innovative optical MRI (oMRI) technique for real-time visualization of clock gene expression patterns within living mammalian brains. This novel imaging method leverages the strength of bioluminescent imaging for molecular speciﬁcity and sensitivity in conjunction with MRI's capacity for whole-brain coverage and high spatiotemporal resolution three-dimensional imaging. If successful, we anticipate this technique will have broad-ranging applications in fundamental neuroscience research and translational investigations for Alzheimer's Disease and other neurodegeneration disorders related to circadian disruptions.